Development of Utrophin Site Blocking Oligos (SBOs) to Treat Duchenne Muscular Dystrophy (DMD)

Duchenne Muscular Dystrophy (DMD) is a common, fatal, genetic disease estimated to affect 1 in 3500 live-
born males. Currently no definitive therapy exists for DMD providing the impetus for urgently developing
therapies to address this unmet need. DMD is caused by mutations in the DMD gene leading to an absence
of the dystrophin protein. Utrophin (dystrophin-related protein/DRP) is the autosomal homolog of dystrophin
sharing extensive sequence similarity and organizational motifs with dystrophin. Utrophin up-regulation can
functionally substitute for the missing dystrophin and ameliorate the dystrophic phenotype of the mdx animal
model of DMD, providing biological validation of this approach. We and others have shown that important
post-transcriptional mechanisms exist that decrease or repress utrophin expression in myofibres, in particular
via binding of miRNAs (e.g. miR let-7c) to the 3' untranslated region (UTR) of utrophin. In a series of exciting
translational studies, we have demonstrated that blocking miR let-7c mediated interaction with the 3’ UTR of
utrophin, using different chemical classes of site blocking oligonucleotides (SBOs), is sufficient to ‘repress the
repression’, increase utrophin expression, and rescue the dystrophic phenotype, in vivo. Importantly, our
Proof of Concept (POC) for this strategy was obtained using a phosphorodiamidate morpholino
oligonucleotide (PMO)-based SBO which has 100% sequence homology to the human utrophin gene, and
hence is ideally suited for translational development. In this BPN proposal responding to PAR 21-163, we
propose to develop SBO-based utrophin upregulators that are appropriate for entry into clinical trials as a
novel therapeutic strategy for DMD.

Public health relevance
Duchenne Muscular Dystrophy (DMD) is a fatal, genetic disease caused by mutations in the DMD gene leading to an absence of the dystrophin protein. Increased expression of a closely related protein called utrophin can ameliorate the disease, hence increasing utrophin expression is considered a promising therapeutic strategy for DMD. We have designed utrophin Site Blocking Oligonucleotides (SBOs) that block the interaction of miRNAs and utrophin mRNA resulting in increased utrophin protein expression and ameliorate the disease in the mouse model of DMD, in preclinical studies. Here we plan to develop these SBOs as a therapeutic to help harness their potential for DMD therapy.